Genomic Research and Data Science Center for Computation and Cloud-Computing

The post-genomic era has transformed biology, medicine and biomedical sciences with this advancement being
increasingly driven by ready access to interdisciplinary collaborative technology-driven databases built within
the accelerating convergence of computational genomics, data sciences, and cloud computing. There is an urgent
need for training the upcoming generation of scientific researchers in this area and effectively drawing upon our
nationwide talent pool. Yet, there remains a distinctive STEM and diversity gap in today’s biomedical workforce
and associated need for transformative change in training in computational genomics, data sciences, and cloud
computing (CGDSCC) to recruit historically marginalized populations. CGDSCC student and faculty training has
been limited among historically black colleges and universities (HBCU) and minority student serving (MSI)
institutions. This is due to a lack of organized resources such as faculty trained in these disciplines, adequate
computing resources, and the instrumentation for conducting genomic research needed to achieve impactful
hands-on CGDSCC student training. In this proposal we seek to provide the educational and hands-
on research training and resources in computational genomics, data sciences, and cloud
computing for the future workforce, particularly among underserved student populations at
North Carolina Agricultural and Technical State University and other target HBCU/MSI
institutions. We have partnered with 3 HBCU’s, North Carolina Central University, Winston Salem State
University and Shaw University, as initial site/target institutions. Additional sites will be recruited if this
proposal is funded. Through the creation of the Genomic Research and Data Science Center for Computation
and Cloud-Computing (GRADS-4C) we will develop and disseminate cloud-based CGDSCC instructional
materials produced with our GRADS-4C affiliated faculty to Target Institutions. This will be accomplished
through the establishment of lasting partnerships with target institutions interested in education, facilitation of
faculty development and student educational and research training in CGDSCC. We shall also develop and
disseminate additional cloud based open source CGDSCC educational resources that can be used with NIH
workflows for the Target Institutions. We are particularly well-prepared to undertake the proposed work due to
the unique team of expert scientists, educators, collaborators, and advisors we have assembled. This innovative
work seeks to formally train the future workforce from underserved populations at minority institutions in
cutting edge CGDS and cloud computing education and hand-on research which has not been attempted or
accomplished before particularly with MSI’s as lead institution. Successful completion of this project will be of
high significance, since it will boost greater overall capacity and critical engagement from an expanded, more
diverse workforce ready to solve complex biomedical/society problems requiring and benefitting from CGDSCC
approaches.
1

Public health relevance
Project Narrative The post genomic era requires interdisciplinary collaborative technology-driven research built upon computational genomics, data sciences, and cloud computing. A lack of organized resources such as faculty trained in these disciplines, adequate computing resources, and the instrumentation for conducting genomic research has contributed to the STEM Talent deficit particularly among historically marginalized communities. Through the creation of the Genomic Research and Data Science Center for Computational Cloud-Computing (GRaDS-4C) we seek to provide the educational and hands-on research training and resources in computational genomics, data sciences, and cloud computing for the future workforce particularly among underserved student populations at NCA&TSU and other target HBCU/MSI institutions.